HEARING LOSS IN INFANTS WITH CMV AS RELATED TO MATERNAL CMV IMMUNE STATUS

This project investigates the relationship between the occurrence of hearing loss and other neurodevelopmental abnormalities occurring in children with congenital cytomegalovirus and maternal seroimmunity during pregnancy to determine if infants with abnormalities are born only to mothers with primary infections.